coRNAucopia - A Method to Deliver Multiple bNAbs in the Same RNA

Development of Next-Generation Devices and Materials-Based Platforms for the Administration of HIV-1 Broadly Neutralizing Antibodies: NIAID and its partners are building on the success of the Antibody Mediated Prevention (AMP) trials by engineering next-generation broadly neutralizing antibody (bNAb) candidates to enhance potency, increase tissue levels, extend half-life, and contend with the ever-evolving global diversity of HIV-1. Developing bNAb cocktails presents additional challenges: complex pharmacokinetics, larger injection volumes, multi-product formulations, and complicated manufacturing. The goal of this program is to support small businesses in the development of devices and/or materials for administration of HIV-1 bNAb(s) and bNAb derivatives (e.g., bispecific antibodies), resulting in increased protection from infection. The goal of this contract is to develop a method to deliver multiple bNAbs in the same RNA.